Probing intracellular Cl- in a WNK signaling-dependent transporting epithelium

? DESCRIPTION (provided by applicant): Disordered renal epithelial ion transport results in hypertension and hyperkalemia, which confer increased risk of cardiovascular complications and death. Data from humans and mouse models indicate that inhibition of with-no-lysine (WNK) kinases in transporting renal epithelia has the potential to ameliorate hypertension and hyperkalemia. Recent work has shown that in vitro, Cl- binds to the WNK active site and inhibits its activation. What is unknown, however, is whether Cl- regulates WNK-dependent transepithelial ion transport. To understand this, the ability to measure and manipulate Cl- in a WNK-regulated epithelium is required. However, this is difficult to achieve in mammalian renal tubules. The applicant's long-term goal is to better understand disease-relevant epithelial ion transport mechanisms by using the Drosophila melanogaster renal tubule. This innovative approach harnesses the ease of genetic manipulation in a physiologically accessible transporting epithelium. The overall objective of this proposal is to develop methods to measure and manipulate intracellular Cl- concentrations within the fly renal tubule. The rationale is to enable a future phase of the project, studying whether and how intracellular Cl- regulates transepithelial ion transport through regulation of WNK signaling. The applicant has previously demonstrated that hypotonicity stimulates WNK-dependent transepithelial ion transport in the fly renal tubule. In other renal epithelia, there is a two-phase decrease in intracellular Cl- after hypotonicity-induced swelling. First, there is a dilutional decrease in intracellular Cl-. This is followed by a further decrease in Cl- as cells undergo compensatory regulatory volume decrease mediated by efflux of KCl. Efflux occurs through potassium-chloride cotransporters (KCCs), and/or parallel K+ and Cl- efflux through channels. In Drosophila cultured cells, bestrophin-1 is the swell-activated Cl- channel. The hypothesis here is that inhibition of bestrophin-1 under conditions of hypotonicity-induced swelling will blunt the lowering of intracellular Cl-, while expression of constitutively active KCC will lower intracellular Cl- in isotonic conditions, in the absence of cellular swelling. This hypothesis will be tested in three specific aims: In aim 1, the applicant will determine the optimal means for measuring intracellular Cl- in the Drosophila renal tubule, testing the feasibility of using a transgenic ratiometric fluorescent Cl- sensor. Aim 2 will determine whether bestrophin-1 mediates swell-induced Cl- efflux from tubule epithelial cells by measuring intracellular Cl- in isotonic and hypotonic conditions, with or without bestrophin-1 inhibition by knockdown or dominant-negative transgene expression. In aim 3, mutations will be introduced into predicted phospho-regulatory serines and threonines to generate a constitutively active KCC. Intracellular Cl- will be measured in isotonic (non-swell) conditions. The proposed research is significant, because it will facilitate development of drugs targeting WNK-dependent epithelial ion transport processes, with beneficial effects on hypertension and hyperkalemia, that have decreased risk of off- target effects due to the unique mechanism of kinase regulation by intracellular Cl-.

Public health relevance
PUBLIC HEALTH RELEVANCE: Disordered ion transport in the kidney contributes to two public health problems, high blood pressure and high potassium levels, that are associated with morbidity and mortality. The proposed research will test the feasibility of experimental approaches that can be used to study the unique mechanisms of regulation of a kinase that regulates ion transport in the kidney. Ultimately, this is expected to lead to the development of drugs targeting this kinase, with beneficial effects on high blood pressure and high potassium levels, and decreased risk of side effects.